Clinical Protocol and Data Management

CLINICAL PROTOCOL AND DATA MANAGEMENT: PROJECT SUMMARY
The mission of the Clinical Trials Core (CTC) is to support SCC members in the development and
conduct of clinical research of the highest quality by providing them with access to an effective,
efficient and economical team specializing exclusively in cancer research. This allows for the
coordination of robust investigator-initiated trials (IIT), innovative industry-sponsored trials, and
active participation in cooperative groups and consortia. The CTC offers comprehensive services
in protocol development, scientific review, regulatory submission, study coordination, data
collection, education, training, financial management, and quality assurance. The CTC has
experienced continued growth during the project period, with a staffing increase of 52% (256 staff
members today). This resulted from a corresponding increase in clinical trial accrual. When
comparing the five-year average from the current project period to the previous project period,
interventional clinical trial accrual increased 77% while interventional treatment clinical trial
accrual increased 25%. There has also been a 30% increase in activation of new pediatric clinical
trials, a targeted area for growth within the CTC. Project growth includes a 52% increase in the
submission of new IITs managed by Protocol Development across the project period. The CTC
has pursued opportunities to reduce protocol activation timelines across all trial types, utilizing
commercial IRBs to reduce IRB approval time by 38% for industry-sponsored trials and by
allowing administrative scientific review for institutional trials that have already received scientific
review committee approval at another NCI cancer center resulting in a reduction of 14 days. In
addition, the CTC employs technology to report key performance metrics and empower
investigators with real-time data related to their projects. In 2015, the CTC launched the OnCore
Clinical Trial Management System (CTMS), which facilitates submission to the PRMS, serves as
a web-based repository for documents that have received regulatory approval, houses an
electronic data capture system for institutional clinical trials readily accessible by investigators
and statisticians, and tracks key metrics including protocol- and accrual-based data regularly
utilized in process improvement projects. The implementation of the OnCore CTMS provided
opportunities for enhanced real-time monitoring of clinical trial accrual to ensure that clinical trial
participation is representative of the population within our catchment area.